Core D: Biostatistics and Data Management Core

CORE D: SUMMARY/ABSTRACT
The University of Michigan (U-M) Udall Center Biostatistics and Data Management Core (BDMC) provides vital
biostatistical support, data management, and analytics for the Udall Center. Core investigators actively
participate and contribute to the national Udall program and the wider Parkinson’s disease (PD) research
community. Aim 1 of the Core is to provide biostatistical and data management support of the Center projects,
including design of experiments, statistical analyses using modern, state-of-the-art statistical models and analytic
methods, result interpretation, and effective dissemination of research findings. Aim 2 is to provide advanced
methods, analytical capabilities, and expertise in the Center, particularly for integrative multi-modal analyses for
the heterogeneous Udall PD data. We offer training materials and educational opportunities for students, fellows,
junior faculty, and research investigators, and community PD advocates. To ensure uniform formats and
vocabularies that facilitate analyses and sharing of resulting data, the NINDS Parkinson’s Disease Common
Data Elements (CDEs) are used. The NINDS Data Management Resource (DMR) repository requires use of
Global Unique Identifiers (GUIDs) that facilitate data aggregation without exposing/transferring Personally
Identifying Information. Data standardization complies with NINDS Parkinson's Disease Biomarkers Program
(PDBP) protocols for storage and access. U-M Udall Center CDE data will be entered into the PDBP DMR using
NINDS ProForms to facilitate data aggregation and sharing with the broader community. Non-CDE data will be
entered into the 21 CFR Part 11-compliant web-based relational database OpenClinica. The Center website will
provide direct links to access summary statistics (data dashboard), manage community requests for samples
and data, and disseminate research findings and computational protocols. The Biostatistics and Data
Management Core will enhance the research, computational and analytic capabilities of the U-M Udall Center,
facilitate PD-related research locally, and contribute unique clinical, biomarker and imaging data to national
repositories for broad community use. Support for the image-based projects, in particular, will require the
integration and harmonization of data across scanners (PET and MRI) and sites (Udall versus Groningen), the
scans (e.g., [18F]FEOBV, [11C]DTBZ, [18F]Fdopa, T1 anatomical, resting state fMRI, diffusion tensor imaging) and
their ensuing modalites (e.g., gray matter density, cortical thickness, functional and structural connectivity, white-
matter integrity), and time (baseline plus follow-up visits). The Center will deploy a number of analysis techniques
to leverage the diversity provided by this multifaceted data set to identify meaningful associations with important
clinical variables involving cognition and gait. Initial emphasis will be placed on hypothesis-driven investigations
targeting individual brain regions of interest, but may be expanded to encompass networks known to be
implicated more broadly in cognitive and gait-related disorders.